Lung vascular ILC3 subpopulation in anti-bacteria immunity and vasculature regeneration

Project Summary
Pneumonia is the only infectious disease in the top ten causes of death in the United States. Bacterial
pneumonia, such as Pseudomonas aeruginosa, induces massive inflammation and vascular damage in the lung.
Therefore, a robust immune response is crucial for the protection and recovery of the lung when the infection
occurs. Group 3 innate lymphoid cells (ILC3s) are emerging as a rapid responder to pathogen invasion in tissues
including the lungs. However, how ILC3s invoke immune responses remains poorly understood. This application,
by two PIs with complementary expertise, seeks to address the issue through combining innovative mouse
models, single cell analysis, 3-D tissue imaging and in vitro assays. Our preliminary findings suggest that a novel
ILC3 subpopulation is localized in the intravascular space of blood vessels (vILC3s) in contrast to the
conventional parenchymal tissue ILC3s (tILC3s). While ablation of both ILC3 subsets causes defects in the
clearance of P. aeruginosa, vILC3s exhibit distinct functions from tILC3s. For example, vILC3s produce the
chemokine CCL4, and neutralizing CCL4 results in decreased neutrophil recruitment. vILC3s also produce the
cytokine macrophage colony stimulating factor 1 (CSF1). Depletion of ILC3s including vILC3s causes impaired
vasculature regeneration accompanied by reduced macrophage accumulation. We therefore hypothesize that
vILC3s are important for bacterial clearance by facilitating neutrophil recruitment, and that vILC3s regulate
vasculature regeneration by modulating macrophage function. Three specific aims are formulated to test the
hypothesis: (1) define the tissue niche and response dynamics of lung vILC3s; (2) test the hypothesis that vILC3s
mediate neutrophil recruitment for P. aeruginosa clearance; and (3) test the hypothesis that vILC3s promote
vasculature regeneration through macrophage expansion. By integrating our expertise in mouse genetics,
immunology, lung regeneration and epigenomics, this research will uncover novel mechanistic insights into tissue
responses to bacterial pathogens, paving the way for new strategies to protect the lungs during infection.

Public health relevance
Narrative Although Innate Lymphoid Cells (ILCs) have been associated with immune defense and tissue remodeling in infections, the underlying mechanism remains largely unclear. This proposed study will determine the role of a novel type 3 ILC subpopulation in host defense against bacteria and vasculature regeneration in the lung. The knowledge gained will provide a framework for identifying new therapy for treating pneumonia bacterial infection and promoting recovery of lung function following infection.